Building Early Awareness and Research in Science (BEARS)

Biomedical and bioengineering research are interdisciplinary fields of science that have led to medical applications, biotechnology innovations and basic research discoveries. However, the lack of educational resources and research opportunities available has limited the number of scientists that pursue biomedical research careers. The Building Early Awareness and Research in Science (BEARS) at California State University San Marcos, a NIBIB ESTEEMED program, will support 15 talented undergraduates interested in bioengineering sciences from matriculation through acceptance into an advanced honors program; the ultimate goal is for them to complete their B.S. degrees, obtain admission to Ph.D. or M.D./Ph.D. programs, and increase the number of biomedical scientists in the nation’s workforce. The three primary goals of the program are to 1) empower BEARS Scholars to accumulate personal, academic and research skills necessary to persist and complete their B.S. degree program, enter an advanced honors program in their junior year, and apply to graduate school in the biomedical sciences; 2) provide a comprehensive mentoring team that supports the academic, research, career, and personal/social/peer needs of the Scholars during their critical first two years; and 3) train BEARS Scholars to be STEM Ambassadors to aid in recruitment, promote local awareness of bioengineering careers, and develop leadership skills. Over three summers and two academic years, the BEARS program combines a variety of workshops and events with leveraged campus opportunities to address several specific aims including: a) strengthen their college survival skills (including mental health), and quantitative and computational readiness in core sciences by participating in an early summer bridge program; b) build their confidence, identity, and communication skills as scientists by participating in workshops, presenting their research findings, and making presentations to high schools and the public; c) foster their passion and interest in biomedical and bioengineering careers by participating in research trainings, activities, and conducting independent research at CSUSM and with partner faculty at UCSD in the Orthopaedic Surgery and Bioengineering Departments. BEARS scholars will then enter one of our highly successful advanced honors programs in which they will receive comprehensive longitudinal faculty mentoring, grantsmanship training, research and peer mentorship that will help them continue their careers into graduate schools and the biomedical workforce. Ultimately, the BEARS program will help increase students entering the bioengineering research workforce.

Public health relevance
The BEARS program at California State University San Marcos will prepare undergraduate students to pursue advanced training in biomedical and bioengineering research. By combining mentoring, coursework, and hands-on research opportunities, the program equips students with the skills and confidence to succeed in graduate education and future research careers. This investment in early career development strengthens the national pipeline of scientists who will drive medical innovation and improve public health.